Developing and Evaluating a Personalized Approach to Initial Fluid Resuscitation in Patients with Hospital-Onset Sepsis

PROJECT SUMMARY
Candidate’s Long-Term Career Goal: Dr. Elizabeth Munroe’s career goal is to become an independent
physician-scientist leading novel clinical trials to improve the early management of critically ill patients.
Clinical Problem to be Addressed: Intravenous fluids are a core component of sepsis management. Yet,
administering both too much and too little fluid can cause harm, and the optimal fluid volume to prescribe is
often unclear. Traditional clinical trials miss the critical window of initial fluid resuscitation and use one-size-fits-
all approaches to fluid resuscitation. Furthermore, like most sepsis research, fluid trials have largely excluded
patients who develop sepsis in the hospital (hospital-onset sepsis), an important and distinct population that
experiences two-times higher mortality than patients with community-onset sepsis.
Specific Aims: In this K23 proposal, Dr. Munroe aims to 1) understand the impact of initial fluid volume on
outcomes in patients with hospital-onset sepsis through an electronic health record (EHR)-based cohort study,
2) develop a personalized, physiology (stroke volume) guided approach to initial fluid resuscitation for patients
with hospital-onset sepsis, and 3) conduct a pilot pragmatic clinical trial comparing personalized, stroke volume
guided initial fluid resuscitation vs usual care during rapid response evaluations.
Candidate Background: Dr. Munroe is a clinical instructor in Pulmonary and Critical Care at the University of
Michigan and current NHLBI NRSA F32 awardee. She will be promoted to Assistant Professor, not contingent
on the outcome of this application. She is recognized as a rising star in the field of sepsis, with 6 first-author
publications, 8 conference presentations, and 5 national invited lectures.
Career Development Plan: Through this project, Dr. Munroe will build on her expertise in sepsis management
and health services research to gain expertise in 1) EHR-data extraction, 2) implementation science-based
intervention design and evaluation, and 3) pragmatic clinical trial design, execution, and analysis. Her 5-year
training plan carefully pairs her training and research aims and is further supported by curated coursework and
career development activities that will position her for successful transition to independence.
Mentors: Dr. Munroe’s primary mentor, Dr. Hallie Prescott, is a sepsis expert who has mentored 5 clinician-
scientists on K-series/career development awards. Dr. Munroe and Dr. Prescott have an excellent track record
of success, working together since 2020. Dr. Munroe will receive complementary support from co-mentors: Dr.
Michael Sjoding (EHR-based data science), Dr. Stephanie Parks Taylor (implementation science), and Dr.
Robert Hyzy (clinical trials), as well a national advisory team with deep expertise in pragmatic clinical trials.
Deliverables: Completing these aims will advance our understanding of fluid resuscitation in hospital-onset
sepsis, generate preliminary data to compete for R-series awards for follow-up trials, and uniquely position Dr.
Munroe to lead novel clinical trials of early interventions in critical care.

Public health relevance
PROJECT NARRATIVE Intravenous fluids are a core component of sepsis treatment, but the optimal volume of fluid to prescribe is often unclear. Both too much and too little fluid can cause harm. This proposal will develop and evaluate a personalized approach to fluid management in patients with hospital-onset sepsis, guided by serial physiologic measurements.